Molecular mechanisms of TAK1 regulation in rheumatoid arthritis

PROJECT SUMMARY
In rheumatoid arthritis (RA), activated synovial fibroblasts (SFs) transform into an invasive phenotype that
recruits immune cells to cause tissue destruction. Recent findings show transforming growth factor β-activated
kinase 1 (TAK1) as a pivotal mediator of IL-1β, TNF-α, and Toll-like receptor signaling cascades due to its central
position upstream of mitogen-activated protein kinases (MAPKs) and nuclear factor-κB (NF-κB) pathways.
However, the molecular mechanism by which TAK1 regulates SF functions to promote RA pathogenesis remains
unexplored. Using FAPα+Thy1+ RASFs, we showed that IL-1β-induced inflammatory signals are suppressed by
inhibiting the TAK1 kinase domain (Thr184/187). Analysis of RNA sequencing data showed that the TAK1 kinase
inhibitors type I (irreversible, 5Z-7-oxozeaenol, 5Z-7o) and type II (reversible, NG-25) significantly blocked the
expression of inflammatory (IL6, CXCL9, CXCL1, NFKB1, and JUNB) and invasive (CDH11, PDPN, SOD2,
PRG4, MMP1, and MMP3) genes in human RASFs. TAK1 inhibitors showed a marked inhibition of (IL-1β+TNF-
α+IFN-γ)-induced IL-6, IL-8, MMP-1, and MMP-3 production and Cad-11, Cox-2, and PDPN expression. 5Z-7o
and NG-25 triggered the nuclear translocation of TAK1 (Ser439) on the C-terminal domain, the function of which
is not characterized. Immunoprecipitation of nuclear TAK1 followed by Western blot analysis showed its novel
interaction with CBP/p300, PCAF, GCN5, and acetylated histone 3, suggesting a role for nuclear TAK1 in
chromatin remodeling. In addition, K63-linked ubiquitination (K63-Ub), a post-translational mechanism that
provides stability to signal proteins, was severely repressed in RASFs compared to non-diseased SFs (NLSFs)
and inversely correlated with increased expression of CYLD, a deubiquitinase specific for hydrolyzing K63-Ub
chains. Treatment of human RASFs with 5Z-7o or NG-25 enhanced K63-Ub proteins in a dose-dependent manner
and transcriptionally inhibited IL-1β-induced CYLD expression. Administration of 5Z-7o or NG-25 (2 mg/kg, p.o.
daily) for 10 days from the onset of the disease significantly ameliorated AIA in rats. However, several questions
remain unanswered, including the nuclear function of the TAK1 C-terminal in chromatin remodeling, its
contribution to the RASF invasive and inflammatory phenotype, and the molecular mechanisms of TAK1
regulation in vivo. Hence, we propose a hypothesis that TAK1 is central to RASF synovial inflammation, and
targeting TAK1 functions may ameliorate RA. Hence, studies proposed in Aim 1 will determine the role of TAK1
in RASF functions and the effect of kinase inhibition on its nuclear translocation and interaction with chromatin
remodelers. In Aim 2, we plan to understand the effect of TAK1 inhibitors on restoring K63-Ubiquitination to inhibit
IL-1β signaling pathways in RASFs. In Aim 3, we plan to study the arthritogenic potential of TAK1 in RASFs and
the mechanism of action of TAK1 inhibitors in collagen antibody-induced arthritis (CAIA) mice, and in fibroblast-
specific TAK1 conditional knockout or overexpressing mice. These findings will provide a mechanism-based
rationale for developing TAK1-targeted therapy for RA.

Public health relevance
PROJECT NARRATIVE Rheumatoid arthritis (RA) is a chronic inflammatory disease, which results in inflammation of the synovial lining and destruction of the adjacent bone and cartilage mediated by RA synovial fibroblasts. In this proposal, we aim to examine the therapeutic importance of TGFβ-activated kinase 1 (TAK1) inhibitors in synovial fibroblasts isolated from RA patient-donated tissues, and in a mouse collagen-antibody-induced arthritis (CAIA) model. Our work will provide a rationale for therapeutically targeting this kinase for the management of synovial hyperplasia, inflammation, and tissue destruction in RA.